Flow Cytometery and Cell Sorting Core

Core B – Flow Cytometry and Cell Sorting Core (Core Lead: Porcelli) Program Lead: Backer, Jonathan M.
ABSTRACT
The Flow Cytometry Analysis and Cell Sorting Core (Core B) will provide access to equipment and expertise
for a variety of advanced flow cytometry-based technologies for single cell level analysis and isolation. The
core will support and maintain a range of advanced instruments for analytic and sorting applications, and will
actively guide the program investigators in applying these to their studies on cancer metastasis. These
methodologies will be applied for the identification, isolation and detailed profiling of cell types of interest and
relevance to the goals of the program project. The resources of the core will be used extensively in all projects
comprising this program, and their organization and support under this structure will provide the Program
investigators with access and technical support in a cost effective way. The key personnel of the core will
have effort dedicated to directly assisting the program PIs in the development and implementation of single
cell analysis techniques relevant to their projects, and assist them in innovating new approaches using the
core technologies. By providing an organizing nucleus for a portfolio of flow cytometry-based single cell
analysis and isolation methods, Core B will create an infrastructure and environment for adapting these
evolving technologies to the needs of the PPG investigators. All of the essential equipment and expertise
required for this core are already in place and available at our institution. Key personnel with the necessary
background and expertise have been recruited from existing faculty and staff, and these individuals have
been designated appropriate levels of effort to ensure proper functioning of Core B. While some of the
equipment and personnel associated with the core are physically housed and partially supported within our
NCI CCSG (P30) funded Flow Cytometry Core Facility, the creation of Core B is essential to the successful
accomplishment of the goals of the PPG, as it will enable the implementation of these technologies for new
and innovative applications that specifically address the studies of cancer metastasis that form the theme of
the current program application.
PHS 398/2590 (Rev. 11/07) Page

Public health relevance
PROJECT NARRATIVE – Core B (Flow Cytometry Analysis and Cell Sorting) Flow cytometry is an essential technology platform for the identification, characterization and isolation of specific cell types. Core B will provide equipment, services and expertise to enable the program investigators to leverage multiple state of the art instruments for analytical flow cytometry and preparative cell sorting. The resources and organization of Core B will ensure efficient and cost-effective application of advanced flow cytometry-based methods to facilitate experiments addressing the fundamental biology of cancer metastasis.